Project 3: Role of Glycosaminoglycans in Hematopoiesis

Project 3 – Project Summary/Abstract
Glycosaminoglycans (GAGs) contribute to myriad, and very often opposing, functions such as cellular
proliferation as well as apoptosis, self-renewal as well as differentiation. Yet, precious little is understood about
the exact GAG sequences that induce these functions. Of particular importance to this program project, although
GAGs are significant components of the bone marrow (BM) microenvironment, the nuts and bolts of whether
GAGs modulate hematopoietic cell fate; whether these interactions are selective/specific; and whether GAG or
GAG-like molecules can be harnessed for therapeutic purposes remain poorly understood. This project focuses
on elucidating the GAG structure–function relationships of importance to hematopoiesis & thrombopoiesis. Three
aims are proposed including 1) Develop Technology for Elucidation of GAGactomes of Biological Samples,
especially Cells and Microenvironment of the Bone Marrow; 2) Employ the Library of Synthetic GAG Mimetics
for Modulation of Hematopoietic Outcomes; and 3) Elucidate Specificity and Function of GAG Recognition of
Sialyl Transferase ST6Gal-1. The outcomes of these aims will be the precise structure–function relationships in
GAGs that induce hematopoietic functions. Specifically with respect to hematopoiesis, the project aims to answer
the question of whether GAGs modulate hematopoietic cell fate. If so, are GAG interactions are selective? If
selective, can GAG sequences or mimetics of GAGs be harnessed as therapeutics for hematopoietic disorders?
Overall, this project contributes knowledge, tools/technology, and therapeutically promising agents in the area
of hematopoiesis and thrombopoeisis.